PROSPECTIVE STUDY OF ANGIOGRAPHIC INTRAHEPATIC PORTO-CAVAL STENT PLACEMENT

To study the role of angiographic intrahepatic stent placement or the acute and long term treatment of bleeding gastro-intestinal varices secondary to chronic liver disease.